Data Management and Analysis Core (DMAC)

ABSTRACT
The Data Management and Analysis Core (DMAC) will be responsible for managing data sets generated, and
performing and supporting biostatistical analyses in the Opti-FliP program. A custom project will be created
and maintained on the UCSF Data Library platform to store, secure, curate, and make accessible all raw and
processed biological data and de-identified clinical data associated with the research program. We will
interface with each project team for data ingestion and provide statistical and bioinformatic support to each.
We will additionally perform multi-modal integrative analyses, including cross-species analyses, to answer
questions within and across each project toward better understanding how vaccine regimens and downstream
T-cell responses influence antibody responses to and prophylaxis provided by vaccination.

Public health relevance
NARRATIVE The human immunodeficiency virus (HIV) has killed approximately 40 million people worldwide. We will participate in an effort to improve prophylactic HIV vaccines by managing the vast data that are generated and participating in their analysis. As a result the vaccine program will be better able to understand the data collected, leverage statistical analyses to advance the scientific field, and share the data via public repositories.